The mechanistic control of bone quality and joint crosstalk by osteocytes

SUMMARY
Bone fragility and joint disease present major challenges to the skeletal and dental health of the aging population.
However, both conditions face a serious treatment gap. For example, therapies for bone fragility treat low bone
mass, but overlook approximately 50% of fractures that result from impaired bone quality. Therapies to prevent
or reverse joint degeneration remain elusive. The long-term goal of this research is to overcome this treatment
gap by elucidating the cellular and molecular mechanisms that maintain bone quality and joint homeostasis.
Ongoing efforts highlight the critical role of osteocytes in both processes, as well as their contribution to bone
fragility and joint disease. Osteocytes play a fundamental role in skeletal homeostasis and disease through the
process of perilacunar canalicular remodeling (PLR). In PLR, osteocytes secrete acid and proteases to
dynamically resorb, and then replace, the surrounding bone matrix. PLR maintains the canalicular network and
bone matrix material properties, a major aspect of bone quality. Indeed, osteocyte-intrinsic disruption of TGFβ
signaling in TβRIIocy-/- mice results in a 65% decline in femoral work to fracture, even with normal cortical bone
mass. Preliminary and newly published data document profound PLR suppression in human osteoarthritis, and
provide evidence that PLR defects play a causal role in joint degeneration in both TβRIIocy-/- mice and in mice
with osteocyte-intrinsic ablation of the PLR enzyme MMP13 (MMP13ocy-/-). Furthermore, PLR is suppressed in
aging bone in much the same manner as in both mouse models. Although these findings suggest a role for
TGFβ, MMP13, and PLR in the age-related decline in bone quality and joint health, the mechanisms responsible
for PLR suppression in aging, or by which PLR suppression contributes to skeletal disease are mostly unknown.
RNAseq of TβRIIocy-/-, MMP13ocy-/-, and aging bone reveals evidence of mitochondrial dysfunction in each model,
a possibility that will be further explored in this project. A computational approach will be used to integrate
genome-wide mouse RNAseq and human GWAS data to improve the identification of novel, clinically-relevant
genes involved in bone fragility and osteoarthritis. These results will prioritize mechanistic gain and loss of
function studies to test the hypothesis that TGFβ-dependent PLR suppression and osteocyte mitochondrial
dysfunction play a causal role in the age-related decline in bone quality and joint health. The proposal pursues
three specific aims: 1) to determine the role of TGFβ and PLR in age-dependent loss of bone quality and joint
homeostasis, 2) to identify PLR-dependent mechanisms implicated in human bone fragility and joint disease,
and 3) to identify mechanisms by which PLR and mitochondrial function are deregulated in aging. These studies
will reveal if PLR suppression in aging represents a common cellular mechanism that drives the temporal decline
of bone quality and joint health, and further, if the unique metabolic control of osteocytes creates opportunities
to specifically target this cell population to improve skeletal and dental health in aging.

Public health relevance
NARRATIVE The active role of osteocytes, cells embedded within bone, in maintaining skeletal health is disrupted with aging. Here we test the possibility that the disruption of osteocyte function with age contributes to age-related bone fragility and joint degeneration. Testing this hypothesis will advance our understanding of the cellular and molecular mechanisms controlling bone quality and joint disease, which will improve the success of clinical efforts to protect musculoskeletal health throughout the lifespan.